SLO family potassium channels: function and physiology

Abstract
The calcium and voltage regulated BK(or SLO1)-type K+ channel is a widely expressed ion channel impacting
on regulation of excitability in a variety of both excitable and inexcitable tissues. SLO1 is encoded by the
kcnma1(or slo1) gene, one of four SLO family members. The ability of SLO family channels to be regulated by
specific cytosolic ions arises from a large cytosolic regulatory domain, containing specific ion binding sites, that
is connected to the pore-forming part of the subunits. The ability of SLO family channels to respond to changes
in the cytosolic milieu makes them uniquely adapted to play negative feedback roles following activity that
leads to alterations in the cytosolic ions. The Ca-regulated BK channel is particularly fascinating, since despite
being encoded by a single gene, it is expressed in a wide variety of cells in each case playing very distinct
physiological roles. A central tenet of the work in this laboratory is that the functional diversity and the
associated broad scope of physiological roles played by BK channels arises from associated with regulatory
subunits. For BK channels, tissue-specific expression of up to four different regulatory β subunits (β1-β4) and
four γ subunits can define BK function and physiology. Our understanding of the loci of expression, channel
composition in particular cells, and the impact of particular regulatory subunits on function and physiology
remains rudimentary. β1 and β4 subunits have been implicated in hypertension and epilepsy, respectively, and
other indications suggest that BK channels may be therapeutic targets in stroke, hypertension, epilepsy, and
tumor growth regulation. To address the gaps in understanding of the roles of BK channels of particular subunit
composition, this lab combines methods ranging from biophysical analysis of channel properties to the use of
genetic knock-out (KO) of specific regulatory subunits. This permits evaluation not only of the biophysical and
functional properties of channels of different auxiliary subunit composition in native cells, but also how these
channels contribute to physiological roles. Furthermore, we continue to probe questions of BK channel function
pertinent to channel inactivation mechanisms and stoichiometry, guided by available structural information.
Recent work on animal models developed in this lab have established important roles of γ1 and γ2 subunits in
defining BK channel functions in secretory epithelial cells and inner hair cells, respectively, while β-containing
BK channels influence action potential firing rates and burst behavior. Future work will further probe our
existing models, e.g., the role of γ1-containing BK channels in colonic epithelium. In addition, a major focus will
be the development of animal models that will allow examination of β3-containing BK currents in native cells.
β3-containing BK channels remain the least understood of all BK channel subunits and we seek to remedy that
deficit. This project is expected to provide new insight into the physiological roles of β3 and γ1 auxiliary
subunits, and the roles of BK channels containing such subunits.

Public health relevance
Project Narrative Four highly homologous genes of the SLO family encode potassium channel pore-forming subunits that are broadly expressed among tissues, share the feature that they are regulated by dynamic changes in specific cytosolic ion concentrations, and broadly influence function and electrical excitability in cells in which they are found. Rich diversity in function of such channels arises from tissue-specific expression of two families of auxiliary subunits (? and ?), which in some cases have been implicated in various pathologies linked to specific SLO family channels, such as hypertension and epilepsy. Using methods of electrophysiology coupled with genetic manipulations that delete specific subunits from mice, this project is a long-term effort to define the functional properties conferred on SLO family channels by their auxiliary subunits, how channels of a specific subunit composition impact on cellular physiology, and whether such channels may underlie any pathological changes in cell physiology.